Neural circuit mechanisms in observational spatial working memory

PROJECT SUMMARY
Observational learning is a type of social learning and a fundamental cognitive behavior in humans and social
animals. How neural circuits in the brain enable this type of learning is not understood. Utilizing an observational
spatial working memory task, where an observer rat learns to first observe the spatial trajectory of a demonstrator
rat and then run the trajectory itself for rewards, this project studies the behavioral and neural circuit processes
underlying reward-directed observational learning. We will focus on a neural circuit hypothesis that interactions
between the hippocampus (HP) and the anterior cingulate cortex (ACC) acquire a vicarious reward signal during
observation and maintain a plan afterward for future spatial trajectories. By conducting behavioral testing,
simultaneous high-density tetrode recording, and closed-loop electrical and optogenetic manipulations in
animals performing the observational spatial working memory task, we will determine key behavioral factors
involved, underlying neural activity patterns and their interactions in HP and ACC, and how behavioral
performances are altered by time- and activity-specific disruptions of HP or ACC neurons. The outcomes of this
study will significantly advance our understanding of behavioral and neural mechanisms in observational learning.
The neural circuit knowledge produced and the manipulations tested in this project may generate novel insights
into how observational leaning is impaired in psychiatric disorders.

Public health relevance
PROJECT NARRATIVE This project studies how a subject learns to obtain rewards in a space by observing another subject’s actions. We will identify neural activities underlying this type of learning task and investigate how task performance can be altered by behavioral and neural circuit manipulations. The outcomes of this study will advance our understanding of neural mechanisms in observational learning and generate insights into how observational learning is impaired in mental disorders.